Maintenance of National Longitudinal Mortality Sutdy (NLMS) and Mortality Disparties in American Communities (MDAC) databases

Funding received through this agreement will be used to support NIA research interests leading to the development of manuscripts from the identified databases that are suitable for publication by NIA approved researchers.